Cortical-Hippocampal Circuit Dynamics for Statistical Learning

PROJECT SUMMARY
Statistical learning (SL) is a fundamental cognitive process that enables the brain to rapidly extract regularities
from continuous experience. SL is a key component of many cognitive functions, for example, the ability to
acquire words during language development. There has been a tremendous amount of behavioral research on
SL, which is now accompanied by a growing neuroscience literature. These latter studies have revealed that
both the cortex (e.g., superior temporal gyrus; inferior frontal gyrus) and the hippocampus are involved in SL.
However, there exists no comprehensive account of what computations these regions perform and how these
regions interact at a circuit level. Further, it remains unknown how SL emerges at increasing levels of
complexity from rudimentary chunking based on transitional probabilities to the acquisition the rules of
nested tree structures, such as in language. The broadest objective of our proposed work is to build and test a
mechanistic neurobiological circuit theory of SL along the hierarchy of SL complexity. We hypothesize that SL
occurs through dynamic interactions between the hippocampus and cortex. Testing this hypothesis requires a
method that is both spatially precise and time resolved (with millisecond timing for quantifying neural
dynamics). We will use non-invasive magnetoencephalography (MEG) in healthy participants alongside
invasive electrophysiology in epilepsy patients, namely intracranial EEG (iEEG) with cortical surface
electrodes and depth electrodes in the hippocampus. With high density hybrid depth electrodes, we will
further enhance the spatial resolution in the hippocampus at the subfield level. To track the rapid evolution of
statistical representations across brain regions, we will employ a novel neural frequency tagging (NFT)
approach. NFT tracks SL by revealing brain rhythms at the frequency of regularities embedded in a continuous
speech stream. Equipped with this cutting-edge toolkit, we will pursue our objectives across 3 aims that explore
the mechanisms of SL at increasing levels of complexity. In Aim 1, we will examine functional coupling
between the hippocampus and cortex during basic statistical learning of transitional probabilities using
subfield resolution hippocampal recordings from iEEG and whole-brain source analysis in MEG. In Aim 2, we
will examine how abstract rule-learning emerges in the brain. In Aim 3, we will investigate how SL unfolds
during learning of hierarchical learning of nested structures. We hypothesize that learning specific vs. abstract
regularities (i.e., rules and nested hierarchies) leads to differential engagement of the hippocampus and
neocortex, respectively, resulting in reversal of information flow between hippocampus and neocortex.
These findings will enhance our circuit-level understanding of SL, advancing the fields of language and
learning, and highlighting potential new diagnostic and therapeutic avenues for comorbid cognitive deficits in
neurological disorders.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to provide a mechanistic neurobiological understanding of statistical learning, a fundamental process that allows humans to rapidly learn about their environment and supports many key aspects of cognition, such as perception and language. Using both non-invasive and intracranial measurements from the human hippocampus and cortex, we will identify the circuit-level mechanisms underlying the acquisition of knowledge based on statistical learning. Understanding these processes would shed light on how the human brain makes meaning from continuous streams of information, and may lead to new diagnostic and therapeutic approaches to neurological disorders.